Research Education Core

RESEARCH EDUCATION COMPONENT PROJECT SUMMARY/ABSTRACT
In Alzheimer’s Disease and Related Dementias (ADRD), a rapidly developing field has gained
comprehensive insights into a host of likely complementary disease mechanisms, shedding light on relevant
genetic and environmental factors, a continuum of neuropathological abnormalities, biomarkers that represent
the earliest stages of disease, and an array of clinical presentations. Yet, large gaps in knowledge remain
regarding disease modeling, genetics and pathophysiology, and of course, treatment. The Columbia University
(CU) Research Education Component (REC) will be a comprehensive training program to effectively and
efficiently develop the next generation of ADRD leaders poised to make breakthroughs in ADRD research
through both established and novel research methods. The CU REC Training Program will provide training for
researchers comprising two distinct groups: a) those entering ADRD research through conventional training
paths (e.g., neurologists, neuropsychologists, basic and translational researchers) with great promise to
contribute to the field in the near term, and b) researchers from non-conventional paths (e.g.,
bioinformatics/data science, engineering, public health, and allied health) who have demonstrated unique and
accomplished research skills, which if reoriented to ADRD, could make novel and important impacts on ADRD
research. The REC Training Program enhances primary aims of the CU ADRC: to enable and enhance
ongoing research efforts in ADRD at CU, and support a diverse group of ADRD researchers making these
discoveries. The CU REC Training Program provides a structured framework that promising junior researchers,
identified through our vast institutional research infrastructure, can leverage to establish successful careers in
ADRD. With ongoing, multidisciplinary mentorship tied to a structured research project, effectively supported
junior researchers can independently develop hypotheses, critically appraise related literature, and frame a
sophisticated approach to an appropriately honed research question. Training will include an individualized
development plan tailored to each trainee and his or her current and future career steps, enabling a
foundational understanding from which to launch a successful research career. This program will build upon
the longstanding practices of the CU ADRC and Department of Neurology, the latter having the highest track
record of trainees becoming academic neurologists of any institution in the world. In sum, the overarching goal
of the REC Training Program is to develop the next generation of ADRD researchers by: 1) identifying 3-5
junior investigators with promise for making significant contributions to the field of ADRD (Aim 1); 2) drawing
trainees from ADRD fields as well as fields beyond traditional pathways to ADRD research, especially those
from diverse backgrounds (Aim 2); and 3) providing all trainees with an individualized development plan that
includes multidisciplinary mentorship, experiences within the expansive internal research and education
program at CU, and an integrated plan to understand how to access and achieve sustained grant support
towards next career steps (Aim 3).